Preclinical Core Component 3

PROJECT SUMMARY
The Preclinical Core supports the mission of the Center for Brain Recovery and Repair by providing well-
validated measures of both structural and functional alterations for investigators utilizing preclinical models of
neurological disorders. The Core is a centralized resource providing intellectual guidance, technical expertise,
training and instrumentation for high quality automated behavioral and structural analyses, broadly applicable
across a range of preclinical models of brain and behavioral illnesses. Through cultivation of new research
programs and collaborative interactions between young investigators and established experts, the Core has
played an essential role in elevating the excellence of brain injury and repair research at UNM. Overall, the goal
of the Core is to leverage our success in Phase I to catapult preclinical research capacity to the critical mass of
funded investigators required to support the Center’s mission of self-sustainability beyond IDeA-level funding.
We will continue to provide the resources and expertise required to support interdisciplinary cutting-edge
research projects of Project Leads in neurophysiological mechanisms of brain recovery and repair, and to
expand our user base of new and established investigators through project development and strategic
investment in state-of-the-art instrumentation, approaches and methodologies. Via the cultivation of innovative
new research programs and increased collaborative interactions between junior investigators and established
scientists the Core will contribute to the sustainability of the Center for Brain Recovery and Repair as a nationally
recognized leader for translational research in brain recovery. Since being established in 2015, the Preclinical
Core has helped advance the field by leading in the development of translational EEG as a platform for assessing
homology of neural activity during behaviors across species. Phase II builds on these successes with the
combination of physiological and behavioral approaches, and adds higher throughput anatomical assessments
to speed studies utilizing sophisticated confocal imaging. Continuing from Phase I, the Core will promote the
Center mission of accelerating the trajectory of Project Leads toward independent NIH-R01 level funding for
Junior Investigators or establishing themselves in the field of brain injury for more senior Investigators. The
Preclinical Core will continue to foster multidisciplinary interactions between clinical and preclinical investigators
at UNM and across the Mountain West. We will also provide a platform for the discovery of novel therapeutic
avenues for brain recovery and repair using preclinical models that will enhance the overall level of excellence
in this vital area of neuroscience research.

Public health relevance
The Preclinical Core is a centralized resource that provides expertise, training and instrumentation to Project Leads and other investigators to accelerate discovery of new treatments for brain injury survivors. The Preclinical Core supports the goals of the Center for Brain Recovery and Repair by providing an essential resource for developing new therapeutic avenues for improving function after brain injury.